Ribonucleotide Reductase as a Driver of Breast Cancer Aggressiveness

PROJECT SUMMARY
Despite the vast improvement in screening techniques and therapies, breast cancer remains the second leading
cause of cancer deaths in females worldwide. Approximately 30% of tumors progress to metastatic disease that
is incurable. Metastatic breast cancers are highly proliferative and thus rely on rapid deoxynucleotide production.
This is supported by increased activity of ribonucleotide reductase (RNR), a multimeric enzyme that is rate
limiting for dNTP synthesis. RNR is an attractive therapeutic target for metastatic breast cancer, with the RNR
inhibitor, gemcitabine, being FDA-approved to treat advanced disease. Inhibition of RNR causes excessive DNA
damage and chromosomal instability (CIN) that inhibits breast cancer cell growth. However, gemcitabine is a
nucleoside analog and, as such, has considerable off-target effects on numerous enzymes and displays severe
dose-limiting toxicities (i.e. myelosuppression, hepatotoxicity). The development of a novel, non-nucleoside RNR
inhibitor would potentially revolutionize patient care by inhibiting tumor growth without the toxicities associated
with gemcitabine. This application describes the evaluation of TMU27a, a first-in-class RNR inhibitor that induces
DNA damage and CIN in breast cancer cells and inhibits tumor growth in a xenograft breast cancer model without
inducing overt toxicities. Proposed studies will expand these analyses to numerous human and mouse cell lines
to investigate the impact of TMU27a on genome stability as well as its efficacy and safety compared to
gemcitabine in preclinical breast cancer models. These studies will determine if TMU27a provides a foundational
agent that is an effective and safe inhibitor of breast cancer growth. In addition, this project will elucidate how
TMU27a binds to and inhibits RNR using cryo-electron microscopy. Preliminary data show that TMU27a tightly
binds to the RRM1 subunit, and it likely binds within the catalytic site. Furthermore, TMU27a is predicted to be
unable to bind in the nucleotide binding pocket of DNA polymerase lambda, a common off-target binding side of
gemcitabine that contributes to its toxicity. Understanding how TMU27a inhibits RNR and blocks tumor growth
will provide an avenue for designing a novel class of non-nucleoside RNR inhibitors that act with high specificity,
potency, and efficacy while avoiding side effects evident with nucleoside analogs such as gemcitabine.

Public health relevance
PROJECT NARRATIVE Nearly 30% of breast cancers progress to incurable metastatic disease, and drugs that block the actions of ribonucleotide reductase (RNR) are used to treat metastatic breast cancer but often cause unacceptable toxicities. This proposal focuses on determining if TMU27a, a newly developed type of RNR inhibitor, suppresses aggressive breast cancer growth and is less toxic than a commonly used drug, gemcitabine. Completing this project will provide a foundation for building new molecules based on TMU27a that can block RNR and are highly effective in the treatment of breast cancer without causing the toxicities associated with currently available RNR drugs.